Mechanisms of persistent neural activity

PROJECT SUMMARY / ABSTRACT
Although many well-studied aspects of neural function involve activity driven by sensory inputs or occurring at
the time of motor actions, the brain often links such ﬂeeting sensory and motor signals with persistent activity.
Somehow, neural circuits and individual neurons are capable of maintaining activity without additional input.
This is a fundamental aspect of neural function and a critical building block of cognition. The mechanisms
underlying persistent neural activity have long been considered in both experiment and theory, but there is little
deﬁnitive mechanistic understanding of the circuit and cellular contributions to persistent activity. Indeed,
theories of persistent activity are far more biologically nuanced than current empirical knowledge— especially
in the nonhuman primate, from which our understanding should have greatest clinical relevance given the
number of disorders that involve persistent activity. Here, we propose work that leverages advanced
techniques for multiple scales (and speciﬁcities) of neural recordings with corresponding analyses of large-
scale datasets to test detailed theories of how the brain generates and maintains persistent activity.
Speciﬁc Aim 1. Establish the marmoset as a powerful complementary model system for dissecting
persistent activity mechanisms in primate brains.
We will demonstrate the viability of studying memory-guided saccades and persistent activity in the marmoset,
using successful training approaches, electrophysiology, and calcium imaging to elicit the key behavior and to
characterize the important brain areas in this exciting primate model system.
Speciﬁc Aim 2. Characterize the large-scale circuitry underlying oculomotor persistent activity.
Using large scale recordings of extracellular activity across multiple brain regions collecting during
performance of a memory-guided saccade task, we will acquire a dataset of unprecedented scale to assess
the large-scale circuitry underlying persistent activity. We will adapt, develop, and deploy advanced statistical
models to capture the functional interactions between neurons and brain areas.
Speciﬁc Aim 3. Test and reﬁne theories of persistent activity with novel measurements at ﬁne spatial
and genetic resolution.
We will perform both 2-photon imaging and high density electrophysiological measures of neural activity. The
imaging will allow us to test the local circuit components of the theory, as well as to assess cell-type-speciﬁc
contributions to persistent activity. High density electrophysiology will reveal the local circuit architecture and
signal ﬂow that are not accessible with coarser techniques. Integrated within our analysis framework, the
resultant model of persistent activity will be supported and reﬁned by multiple scales and forms of empirical
evidence, all collected in the primate brain.

Public health relevance
PROJECT NARRATIVE The proposed work aims to understand the cellular and circuit contributions to persistent neural activity, thought to be the neural basis of working memory and a building block of many forms of cognition. Deﬁcits in these functions are evident in Parkinson's disease, Alzheimers, schizophrenia, and a number of other brain diseases. Being able to repair or replace the mechanisms of persistent activity would be of signiﬁcant clinical relevance to this large set of human health challenges.